D-RIBOSE &D-RIBOSE/DOBUTAMINE IDENTIFY VIABLE MYOCARDIUM/TREAT ISCHEMIC MYOCAR.

Patients with ischemic left ventricular dysfunction whoa re suspected of having stunned or hibernating myocardium will be enrolled in this study to evaluate the safety and efficacy of D-ribose infusion for improving myocardial wall motion abnormalities detected by echocardiography.